Text-messaging Communication Micro-Intervention for Couples Coping with Advanced GI Cancer

A cancer diagnosis requires patients and their intimate partners to communicate effectively to navigate illness-
related challenges. Research indicates that couples who use effective communication strategies have better
individual psychological adjustment and higher relationship satisfaction. However, many couples have difficulty
communicating about cancer-related issues which can lead to poorer individual, relationship, and patient health
outcomes. While dyadic interventions to improve couple communication have proven efficacious, they are
often time intensive and have limited reach. The challenges of recruiting couples into dyadic interventions are
well-documented, with low recruitment rates especially among underserved couples. Micro-interventions,
which consist of brief educational materials and short activities delivered via text message or a mobile
application, have significant potential to increase reach and participation in diverse groups of couples by
increasing flexibility and reducing barriers to access. Previous studies have found micro-interventions to be
effective in promoting health behavior change in a wide range of individuals and in enhancing dyadic
functioning in community couples. To date, there are no existing micro-interventions that have been developed
and tested in couples coping with cancer. Therefore, the proposed project aims to develop, and pilot test a
text-messaging micro-intervention focused on improving communication skills for couples coping with
advanced gastrointestinal (GI) cancer. The content of the dyadic micro-intervention will be adapted from
existing, empirically validated couple-based interventions developed for cancer and non-cancer couples. Aim 1
focuses on developing the micro-intervention through focus groups and interviews with couples coping with
advanced GI cancer and community advisors representative of minority groups, along with user experience
testing with the target population. The data collected will be used to increase content relevance, acceptability,
feasibility, and cultural sensitivity of the micro-intervention. Aim 2 will be a randomized pilot test of the dyadic
micro-intervention to assess feasibility and acceptability. Aim 3 will examine pre-to-post intervention outcomes
as measured by improvements in relationship satisfaction and constructive communication. This project is in
line with the National Cancer Institute’s priority research area of cancer survivorship and has the potential to
increase health equity in cancer by increasing participation of underserved couples. The proposed project will
provide training in 5 key areas for the applicant: (1) psycho-oncology and cancer control, (2) theories and
didactics related to the development, implementation, and dissemination of behavioral interventions in the
context of cancer, (3) mixed research methods specific to development of psychosocial interventions, (4)
health equity, diversity, and inclusion training, and (5) professional development. The unique and extensive
resources available at Duke University Medical Center, including the Duke Cancer Institute, will aid and
enhance training, scientific productivity, and successful completion of the proposed project.

Public health relevance
Project Narrative Many couples have difficulty communicating about cancer-related concerns, which can impede their ability to cope with the disease, lead to increased psychological distress, and negatively impact the quality of their relationships. While efficacious, couple-based communication interventions have limited uptake due to their time-intensive nature; the proposed research project aims to address this problem by developing and pilot testing a text-messaging communication micro-intervention to increase reach and participation in couples coping with advanced cancer. If successful, we will have developed a brief, targeted, and scalable intervention that could be integrated into routine oncology care, resulting in better outcomes for both patients and their family caregivers.